REPOSITORY SERVICES FOR MPIDB PH700 - NICHD HUMAN BIOSPECIMEN REPOSITORY

The Maternal and Pediatric Infectious Disease Branch (MPIDB) promotes research to investigate the impact and treatment of HIV, its complications, and other significant infectious diseases in infants, children, adolescents, and pregnant and nonpregnant women. This includes PHACS, a multicenter United States-based program that follows both perinatally HIV-infected youth and HIV-exposed/uninfected infants, children, and youth. This task order is for Pediatric HIV/AIDS Cohort Study (PHACS) sub-study (PH700), entitled “Evaluation of Biomarkers for Triage of HPV Positive Cervical Cancer Screening in HPV-Vaccinated Women Living with HIV”, led by Dr. Barbara Moscicki. This Task Order requires repository services for approximately 14,040 barcoded tubes to be sent to the repository over the next three years.